2023 Functional Genomics of Human Brain Development and Disease Gordon Research Conference

Project Summary/Abstract
This 2023 Functional Genomics of Human Brain Development and Disease GRC conference seeks to bring
together a multidisciplinary and diverse group of geneticists, neuroscientists, and stem cell biologists
endeavoring to improve diagnostics, prognostics, and treatment of brain disease. The conference will explore
(1) genomics of brain diseases, (2) applications of high-throughput genomic assays and screens, (3)
technological advances in reprogramming, differentiation, and genome-engineering; (4) new insights into
human brain development and disorders obtained through technologies; and (5) progress towards novel
therapeutic targets and interventions. Whereas large-scale genomic studies are uncovering the complex
genetic architecture of gene regulation and disease risk, the causal cellular mechanisms of disease risk and
progression remain unclear. While the generation of patient-specific neurons, glia, and organoids facilitate the
study of human brain development, CRISPR-based engineering approaches facilitate single or genome-wide
perturbations in DNA sequence or epigenetic activity; their integration makes it possible to investigate the
molecular mechanisms of disease-associated variations. Together, these approaches translate the myriad
advances from large-scale genetic studies into clinically actionable information.
This 2023 Functional Genomics of Human Brain Development and Disease GRC conference will contribute to
improving our understanding the cellular and molecular mechanisms involved in regulating human brain
development in health and disease. The attendees are also expected to form new connections with the leaders
in industry and academia for setting new collaborations and starting new careers.

Public health relevance
Project Narrative: The 2023 Functional Genomics of Human Brain Development and Disease GRC will discuss new approaches for modeling human brain disorders associated with neurological, psychiatric, and neurodegenerative abnormalities. This 2023 conference is relevant to public health because it will discuss recent advances and the remaining limitations associated with modeling these abnormalities using human stem cells and genome editing tools. The conference also includes activities to enhance diversity.